Data Mgmt & Analysis Core - The NINDS International Stroke Genetics Consortium St

The Data Management and Analysis Core by design will include statistical experts across multiple centers to foster the collaborative nature of this project